Genome Sequencing of Foodborne Pathogens by the Pennsylvania GenomeTrakr Group

Project summary/abstract (Project) The state of Pennsylvania has been a member of the Food and Drug Administration’s GenomeTrakr network since Fall 2016, as a collaboration between Penn State and the Pennsylvania Department of Health (PADOH). This consortium successfully completed all requirements of being a member to date, while also providing training in genome sequencing and analysis to state lab members, and to undergraduate, graduate, and post- graduate students. This proposal describes the continuation of these projects for the next funding cycle, as well as expanded efforts to obtain and distribute food and agricultural isolates to other GenomeTrakr labs for whole genome sequencing.

Public health relevance
Project Narrative (Project) This project describes the continuing efforts by the Pennsylvania GenomeTrakr consortium to assist the United States Food and Drug Administration with their goals of populating databases with ever more genome sequences of foodborne pathogens. We will do so while engaging with and training organizations that have limited access to this technology.